Emerging and Re-Emerging Pathogens Research Training Program in DRC (EREP-RTP-DRC)

The Democratic Republic of the Congo (DRC) has recorded high burdens of emerging infections, including
Ebola, Mpox, COVID-19, and drug resistant TB in recent years. DRC has a long-term unmet need for durable
and sustainable local research capacity and common frameworks for national and regional preparedness to
mitigate outbreaks before local and global spread. To address this challenge, we propose the establishment of
an Emerging and Re-Emerging Pathogens Research Training Program in the DRC (EREP-RTP-DRC), based at
the National Institute of Biomedical Research (INRB) and in partnership with Stellenbosch University, Cape
Town, South Africa, the University of Antwerp and the Institute of Tropical Medicine in Belgium; and Boston
University, the University of California Los Angeles, and University of Pittsburgh in the US. The proposed
comprehensive training program leverages relevant expertise from well-established and highly productive South-
South and North-South global health research collaborations. The overall objective is to build a critical mass of
the next generation of basic, translational, clinical, and public health scientists and technical staff who will
become global research leaders capable of responding to emerging and re-emerging pathogens in the
DRC. The specific aims are: 1) To acquire research methodology skills through long-term degrees (e.g.,
Masters, PhD) or short-term non-degree trainings (e.g., postdoctoral fellowships, workshops, laboratory
internships); 2) To conduct mentored research projects on Ebola virus disease, Mpox, COVID-19 or drug-
resistant tuberculosis to answer new, locally relevant questions and test meaningful hypotheses; 3) To become
proficient in scientific presentations and writing, grantsmanship, research ethics and management; 4) To
evaluate the outcomes of this program and make adjustments as needed and acquire skills to translate research
findings into clinical practice and public health policies. We will achieve these aims using an innovative North-
South and South-South triangular mentoring model. Each trainee will have one core mentor based in the DRC
and one co-mentor from collaborating institutions. Most long-term trainings will take place in South Africa and
research will be conducted in the DRC, while short-term training will take place at any European or US partner
institution. After consultation with an independent Training Advisory Committee, a Steering Committee will
approve the recruitment, research projects, monitoring, and evaluation of 17 highly competitive trainees (6
Masters, 4 PhD, 5 post-doctoral and 2 lab technicians), each of whom will be supported with a seed research
grant and protected research time. Each trainee will have an individualized career development plan that will be
monitored during training and for the next five years following program completion.

Public health relevance
There is an urgent need to build a critical mass of well-trained research scientists, technicians, and logistics personnel who are prepared to confront endemic, emerging, and re-emerging infections in countries most affected by them, such as DRC. Given the EREP-RTP-DRC team’s scientific pedigree and extensive past and present experience in pandemic response, trainees will have unique opportunities to conduct mentored-research projects of local and global significance and high clinical and/or public health impacts while advancing their career paths. A broad range of expertise will be needed, to include genomics and bioinformatics, immunology/vaccinology, vector biology, epidemiology and biostatistics, clinical trials, implementation science, behavioral sciences, laboratory techniques, grant and scientific writing, and research grant administration.